Administrative Core

SUMMARY – ADMINISTRATIVE CORE
The Administrative Core (AdminC) advances the mission of the Center for Environmental Health and Justice in
Northern Manhattan (CEHJNM) by providing leadership and support to promote the Center’s strategy.
Specifically, the AdminC coordinates and integrates CEHJNM components and activities, provides financial
oversight, facilitates interactions with other environmental health sciences Core Centers and the National
Institute of Environmental Health Sciences, and evaluates the productivity and effectiveness of the Center’s
activities.
The AdminC also houses the Center’s Career Development Program (CDP). Within Columbia University, the
CDP supports early-career investigators with development awards, mentoring, and training; it also supports
early-career, mid-level, and senior investigators with services and enrichment activities to facilitate the pursuit
of new paths in environmental health sciences. Nationally, the CDP will support and partner with Agents of
Change in Environmental Justice. This nationwide program supports the careers of early-career scientists from
historically excluded backgrounds through leadership development and science communication training.
CEHJNM currently boasts 62 members (44 full and 18 associate) from 15 units across the Mailman School of
Public Health, the Climate School, and the College of Physicians and Surgeons. The CEHJNM added 29 new
members over the past five years, including 21 newly recruited to Columbia University’s faculty. In parallel, the
Center’s high-impact research has vaulted Columbia University to the #1 position in NIEHS extramural
funding—in fiscal year 2021, CEHJNM’s members administered 42 projects and $20.1M in total NIEHS
funding, up from 24 projects and $11.5M in 2017. The AdminC will supervise the utilization of resources,
manage the budget, coordinate Center activities, support the Pilot Project Program by operating the application
process and award workflow, and coordinate the Center’s media strategy. The AdminC will also partner with
the Internal and External Advisory Committees, the Community Engagement Core Advisory Board, and
CEHJNM’s scientific evaluator to assess the Center’s organization and activities, identify challenges, and
develop new directions.
The AdminC will facilitate CEHJNM’s activities and operations within the vibrant Columbia University
environmental health community as we tackle the most pressing challenges of our time. Through these
activities, the AdminC plays a crucial role in helping the CEHJNM promote science and translation to
understand environmental challenges, address environmental inequities, and prevent disease caused by
environmental exposures.